Role of Nitric Oxide in Regulating Inflammation and Gene Expression

Nitric oxide (NO) is an important inter- and intracellular messenger implicated in the pathogenesis of septic shock. Inhibition of nitric oxide synthase is under investigation as a treatment for hypotension in septic shock. In addition to the vasodilating effect of nitric oxide, this messenger also has effects on platelets and immune cells. In this investigation, we are examining the role of the nitric oxide pathway as a modulator of immune cell function and gene expression. We have been unable to create conditions under which human phagocytes, in particular neutrophils, endogenously produce nitric oxide (J Immunol: 1825, 1994). Therefore, the ability of nitric oxide produced by other cells, such as endothelium and epithelium, to alter the function of human phagocytes is being explored. We have confirmed that nitric oxide regulates cytokine production using a U937 monocytic cell line transfected to express murine-inducible nitric oxide synthase (Blood: 1160, 1997). Further investigation of this effect has resulted in the description of a cGMP-independent signaling pathway for nitric oxide (J Biol Chem: 5959, 1997). We have found that in addition to upregulating tumor necrosis factor alpha (TNFa) production (J Immunol: 4102, 1994), nitric oxide modulates interleukin-8 (IL-8) message transcription and release in human neutrophil preparations. However, contrary to other reports, nitric oxide does not directly alter neutrophil chemotaxis (J Infect Dis: 116, 1998). More recent work has iden-tified a NO-response element in the TNFa promoter (manuscript submitted). Currently experiments are aimed at generalizing the role of this putative NO-response element to the IL-8 promoter and several unrelated promoters. Further, the importance of sequences flanking this NO-response element to its function are being investigated.